Perinatal cardiomyocyte pruning driven by metabolic maturation: Opportunity for intervention

Project Summary
Cardiac myocyte number is a fundamental determinant of heart function which, due to progressive cell loss,
becomes especially important when the heart is stressed, such as when there is pediatric or adult heart disease.
Although intensive medical effort is focused on sparing myocytes during the disease process and there is intense
(as-yet unrealized) interest in restoring numbers through stem cell therapies, no work has been done to address
the large perinatal loss of cardiac myocytes. This is a therapeutic opportunity to increase life-long cardiac
myocyte number substantially. What is not known are the exact timing of the cell loss in the peripartum period,
and the signals in the near-birth cardiac milieu driving the cell loss.
In the same window during which myocyte loss occurs, the fetus faces increasing hypoxia, the fetal heart
undergoes metabolic maturation in preparation for the high-fat milk diet to come immediately after birth, and
thyroid hormone increases many-fold. The interaction of these three factors likely contribute to cardiac myocyte
loss via oxidative stress and apoptosis. Further, male fetuses are notable for having “risky” in utero growth
strategies which may lead to increased sensitivity to pathological developmental programming. We suspect that
the interactions of these signaling pathways render hearts susceptible before birth, but that oxidative stress and
cell death can be suppressed by an antioxidant.
In this study we will use a large animal model (sheep) to examine both isolated (in culture) effects of these
regulators on metabolism and apoptosis, as well as their role in the more complex in utero environment. We will
use the Seahorse Bioanalyzer to measure cardiomyocyte respiration with different metabolic substrates and
under different test conditions. We will also measure cell death, as assessed by cell number, enzyme release
and activity, and apoptotic and autophagic pathway activation. We will tie these results in to reactive oxygen
species generation and activation of cell death pathways. We will also determine if melatonin supplementation
to reduce oxidative stress prevents the near-term loss of cardiac myocyte number.
Significance: Heart failure can be reduced by increasing the number of healthy cardiac myocytes. Myocyte
endowment is substantially reduced around the time of birth in an event that represents a powerful opportunity
for intervention. We aim to increase myocyte number at birth by targeting the connection between metabolic
maturation, hypoxia and cell loss in a translational model applicable to human physiology.

Public health relevance
Project Narrative: Infants and adults who have congenital heart disease or other risk factors such as prematurity would benefit from more cardiac myocytes to prevent heart failure. We think that many fetuses lose an abundance of myocytes from their hearts during in utero metabolic maturation immediately before birth. We are seeking to increase cardiac myocyte number by reducing this loss through intervention targeting oxidative stress.